Psychotropic compounds from wastewater contamination affect nervous system development

Abstract
The receiving water bodies that are sources of drinking water are continuously contaminated with psychotropic
drugs – those that target the nervous system - through wastewater treatment facility effluent. Without
mechanisms to remove or neutralize them, these drugs can reach the drinking water, cross maternal biological
barriers, and alter embryonic gene expression. Is it not known how chronic exposure to the composite mixture
of these drugs, including antidepressants and narcotics, even at very low doses, may represent a risk to human
health. Psychotropic medications are among the most commonly prescribed drugs in the U.S. Together with
psychotropic illicit drugs, a significant portion of these medications and their active metabolites are discharged
into the receiving water bodies. With the prevalence of drugs in wastewater ever-increasing, so does the urgency
of understanding the risks. Our central hypothesis is that developmental exposure to low levels of psychoactive
drugs through contaminated water sources affects gene expression in the developing nervous system with
behavioral consequences. This proposed basic biomedical research will expose developing zebrafish to an
environmentally-relevant combination of psychotropic compounds to evaluate the effects of this form of exposure
on gene expression and function of nervous system. Quantitative RT-PCR and in situ hybridization will be used
to explore nervous system-specific changes in gene expression following drug exposure. A battery of larval
behaviors ranging from basic locomotion to cognitive tasks will assess the functional consequences of
developmental drug exposure. Finally, sensitive behaviors will be used to evaluate potential synergism between
drugs. By raising zebrafish in dosed water as a proxy for human prenatal exposure through contaminated water,
these experiments will identify sensitive behaviors and genes that are expressed in developing neural tissues.
Strengthening the evidence that exposure to subtherapeutic levels of these drugs has adverse effects on
development may inform intervention to remediation measures to reduce the risk to human health.

Public health relevance
Narrative Wide ranges of drugs with overlapping neural targets contaminate our drinking water sources, and we hypothesize that this route of exposure affects gene expression in brain regions with functional consequences. By raising zebrafish in dosed water as a proxy for prenatal human exposure through contaminated drinking water, undergraduate-led projects will identify behaviors and genes that are sensitive to this type of sub- therapeutic, potentially synergistic, and chronic exposure.